hANDY-i(TM): A non-invasive, dual-sensor handheld imager for intraoperative preservation of parathyroid glands

Abstract
Post-surgical hypoparathyroidism or hypocalcemia are known to occur frequently after thyroid surgeries
due to the misidentification and/or accidental removal of healthy parathyroid glands. Approximately
150,000 thyroidectomies are performed in the US, 27% of these patients suffer from transient or
permanent hypocalcemia, which can lead to lifelong sequelae and socioeconomic burden. Because of
the small size, the variable position, and the similar appearance to the surrounding tissues such as
lymph node, fat, and thyroid gland, it is often difficult for low volume surgeons to distinguish parathyroid
glands from thyroid tissue. Furthermore, blood supply to parathyroid glands is fragile and can be
damaged easily during dissection. This is a challenging problem because it is clinically hard to tell by
visual inspection if a gland is still viable after manipulation. There are currently no standardized or
practical equipment available to localize and assess viability of parathyroid glands in real time and in a
non-invasive manner during operation. Thus, any viable solution would be considered as significant to
the endocrine community.
In this research, we propose to develop a non-invasive, handheld imager that will potentially be a
paradigm changing tool for patients with thyroid tumors. Our imaging solution, called hANDY-iTM, will
permit 1) a non-invasive parathyroid gland identification and 2) seamless display of tissue viability in
real-time for the preservation of the parathyroid glands during thyroid surgery. This research will be a
joint effort combining the technical and clinical expertise of Optosurgical, LLC and Johns Hopkins
Hospital. To validate our hypothesis, we will study the following specific aims; Aim1: Clinically viable
prototype development; Aim 2: Clinical trials to validate the proposed system (N=64); Aim3:
Premarket device evaluation.
We envision that our technology will open a new door for the digital imaging paradigm of dye-free,
temporally unlimited, and precise parathyroid detection and preservation. Successful translation of this
technology will potentially reduce the risk of hypoparathyroidism during thyroid surgery and improve
the clinical outcomes.

Public health relevance
Narrative The parathyroid glands are small tissues in the neck that play a key role in maintaining calcium levels of the body. In thyroid surgery, serious complications such as post-surgical hypocalcemia (low calcium in the blood plasma) can occur when one or more of the parathyroid glands are unintentionally injured or removed due to their small size and similar appearance to the surrounding tissues. We propose to develop a non-invasive camera to aid surgeons to effectively and safely preserve parathyroid glands during operation, thus optimizing surgical decision-making and ultimately contributing to improved outcomes.